Pooling International Cohort Studies of Long-Term Bisphosphonate Use and Atypical Femur Fractures

Project Summary
Use of bisphosphonate (BP) medications for the prevention of fractures is declining, partially due to patient and
provider fears about the occurrence of atypical femur fractures (AFF), which are clearly associated with long-
term bisphosphonate use. Many individuals are choosing to not use these medications at all rather than risk
having this rare outcome. This decision may leave individuals at high risk of morbidity and mortality. Balancing
the risk of typical osteoporosis-related fractures, such as hip or vertebral fractures, with the risk of the much rarer
AFF, is an important component of decision-making by physicians and patients about medication use. Further,
an understanding of which subgroups of women may be at greater or lesser risk of AFF will be useful when
making clinical decisions about initiation of medication, duration of treatment, and use of drug holidays. The
proposed study will address these issues by combining individual-level data from three large, population-based
cohort studies with radiographically verified AFFs, comprehensive longitudinal medication exposure, data
harmonized definitions of other covariables, and centrally coordinated statistical programming. We will be
focusing on two Specific Aims. In Aim 1, we will examine the risks of long-term use of BP for the prevention of
AFF by determining the independent effects of BP treatment and drug holidays on AFF risk, including the
potential interplay between pre-holiday duration of treatment and duration of holiday. In novel exploratory
analyses, we will determine the effects of re-initiation of BPs after a drug holiday. We will also evaluate the
relationships between AFF risk and the use of other fracture prevention medications (e.g., intravenous BPs,
denosumab and SERMs), other potential risk factors (e.g., physical activity, bone mineral density (BMD), race),
and comorbidities. In Aim 2, we will use the pooled data from our 3 cohorts to develop and validate predictive
models incorporating patterns of long-term BP treatment, drug holidays and clinical risk factors, to
comprehensively model the expected fracture protection and potential harms for individual patients and evaluate
the group-level balance between AFF risk and osteoporosis-related fracture prevention. These models will allow
clinicians to quantify individualized risk, balancing the benefits and harms of bisphosphonate treatment
accounting for other risk factors. Development of these predictive tools and addressing important gaps in the
scientific evidence related to BP treatment, drug holidays, and re-initiation of BP or other anti-osteoporosis
medications will have an immediate positive impact on clinical practice and patient care by encouraging and
improving the optimal use of osteoporosis medications.

Public health relevance
Project Narrative Osteoporosis medications are extremely effective in reducing hip and spine fractures, however, their use has declined dramatically over the past decade, partially due to concerns about a rare adverse event called atypical femur fractures (AFF). Our project, which includes data from 3 large, population-based studies of AFF, will help identify women at particularly high or low risk for AFF, facilitating the development of prediction models and risk score tools. These tools will enable providers to individualize their recommendations to patients about the use of these important medications for managing osteoporosis, balancing AFF risk against osteoporosis-related fracture prevention.